Defining mechanisms of perianal fistula inception in African and European ancestry Crohn's disease patients

PROJECT SUMMARY
Crohn’s disease (CD) is characterized by progressive, transmural inflammation that can affect any region of the
gastrointestinal tract. Penetrating complications, most often perianal fistulae, will affect up to 50% of CD patients
over their disease course. Perianal fistulae are a high morbidity CD complication with poor treatment response.
African ancestry (AA) patients have higher rates of perianal disease, including perianal fistula, than European
ancestry (EA) CD patients. Many of the genetic advances of the genome wide association era are from studies
wherein AA patients are underrepresented. PTGER4 is the only risk locus with strong association signals in AA
populations. There is a need to include AA patients in genetic and genomic studies of CD, particularly in the
context of perianal fistula, to better understand drivers of disease and improve clinical outcomes.
Aim 1 seeks to construct a single cell genomics cohort of AA and EA patients with a history of perianal fistulizing
CD. To date, there is no single cell sequencing dataset of CD samples with a focus on the rectum or fistula, nor
a dataset comparing single cell gene expression between these ancestry groups in CD. We will perform CITE-
sequencing on resection tissues from proctectomies and colectomies in patients with severe CD and history of
perianal fistula. We will also collect rectal biopsies from areas of active inflammation and from un-involved rectum
or colon for single cell RNA sequencing. From these data, we will identify differential gene expression modules
that will be validated by projection onto available bulk RNA sequencing data from larger CD patient cohorts.
Single cell capture of both RNA and protein expression will provide unprecedented granularity into cell
populations important in fistula progression and illuminate any differences between patient populations.
In Aim 2, we will further explore drivers of fistula pathogenesis. We identify IL-17 and PGE2 signaling as
candidate pathways that influence epithelial integrity in the context of inflammation and epithelial-mesenchymal
transition (EMT), promoting fistula inception. We will culture epithelial monolayers long-term from patient-derived
organoids to model epithelial differentiation, barrier function, and EMT. We will use this system to assess the
effects of PGE2 and IL-17 receptor agonism and inhibition on epithelial cells, and how this may influence wound
healing and mediate fistula inception. In this way, we will be able to interrogate specific signaling pathways and
their contributions to epithelial health using functional readouts.
The academic environment at Mount Sinai is unparalleled to perform this work. Mount Sinai is home to pioneers
in IBD clinical care and research, who collaborate in meaningful ways while working with one of the most diverse
patient populations in the world. The training plan for this fellowship takes full advantage. Together, the studies
described herein will provide important insight into perianal fistula inception and which gene modules might make
a patient susceptible. This proposal combines direct ex vivo single cell genomics with in vitro functional studies
for a robust inquiry into a high morbidity complication that affects diverse patient populations.

Public health relevance
PROJECT NARRATIVE Perianal fistulae are a complication of Crohn’s disease with poor treatment response that affects patients of African ancestry more frequently and with greater morbidity. These studies will explore differences in protein and gene expression between African and European ancestry patients with perianal fistula at the single cell level, and establish an in vitro rectal organoid model to characterize the lipid and cytokine mediators that contribute to fistula inception. The combination of these approaches will better define gene modules that distinguish perianal fistulizing Crohn’s disease between ancestry groups and inform the discovery of novel targets for the treatment of perianal fistula.